Investigating Resistance Mechanisms to Non-covalent Bruton's Tyrosine Kinase Inhibitors and Therapeutic Approaches to Overcome Resistance for Patients with B-Cell Malignancies

PROJECT SUMMARY
B-cell malignancies such as chronic lymphocytic leukemia (CLL) and other forms of Non-Hodgkin
lymphomas (NHL) are common hematologic malignancies typically occurring in adults. These malignancies
arise from dysfunctional, mature B-cells. Irregular signaling of the B-Cell receptor (BCR) pathway can lead to
proliferation and survival of B-cell malignancies making Bruton’s tyrosine (BTK), a kinase early in the BCR
pathway, an attractive target for cancer therapy. While available treatments can lead to disease remission,
nearly all patients relapse, leading to the consensus that CLL remains to be considered an incurable disease.
Covalent (irreversible) small molecule inhibitors of BTK, such as ibrutinib, have transformed the management
of CLL, mantle cell lymphoma (MCL), and Waldenström’s Macroglobulinemia (WM). Covalent BTK inhibitors
are efficacious in multiple B-cell malignancies, however due to resistance and intolerance, many patients
discontinue these agents. To overcome these problems, highly selective and reversible non-covalent BTK
inhibitors have been developed. They are currently being tested in clinical trials showing safety and promising
efficacy in multiple B-cell neoplasms, including heavily pre-treated CLL, MCL, WM, and follicular lymphoma,
demonstrating that non-covalent BTK inhibitors might address a growing unmet need for alternative therapies
for these patients. Despite the beneficial features of pirtobrutinib and a high overall response rate seen in the
Phase 1 studies, some patients with previously treated CLL and B-cell malignancies did not respond to
treatment or relapsed after initial response to monotherapy.
Based on next-generation mutational analysis of BTK, PLCG2, and additional genes recurrently mutated
in CLL prior to non-covalent BTK inhibitor therapy and at the time of on treatment progression, we have now
identified novel BTK and PLCG2 variants that were only detectable post-treatment. Given these preliminary
findings, I hypothesize that on-target mutations within BTK or the B-cell receptor signaling pathway (such
as PLCG2 mutations) result in resistance to non-covalent BTK inhibition and that combining BTK
inhibitors with other CLL targeting drugs will circumvent said resistance. Currently, there are no reports
of resistance mechanisms to non-covalent BTK inhibitors in patients. This proposal will identify the mechanisms
by which cells develop resistance to non-covalent BTK inhibition and challenge that resistance with additional
targeted therapies in the following aims: Aim 1: Identify the mechanism underlying novel BTK mutations
observed in acquired resistance to non-covalent BTK inhibition. Aim 2: Test combination therapies to overcome
resistance to BTK inhibitors in B-cell lymphoma. There is an exponential need for therapeutic alternatives due to
an increased incidence of patients with acquired resistance. The results of this study will have a major impact
for patients with a variety of B-cell malignancies. Additionally, these findings will inform the development of
rational combination therapies with non-covalent BTK inhibitors.

Public health relevance
PROJECT NARRITIVE: B-Cell lymphomas, such as chronic lymphocytic leukemia (CLL), account for the majority of all non-Hodgkin lymphomas (NHL). While highly selective and reversible non-covalent Bruton’s Tyrosine Kinase (BTK) inhibitors have transformed the therapeutic landscape for patients, resistance to the inhibitors is still observed leaving a knowledge gap in therapeutic options. Based on preliminary data of patient sequencing before treatment and at the point of treatment progression, my research will be among the first to identify the specific mechanisms of resistance and help generate therapeutic approaches to overcome resistance.